Cocaine effects on spatial patterns of striatal dopamine release

ABSTRACT
A key feature of cocaine use disorder (CUD) is deficits in dopamine release in the nucleus accumbens core
(NAc). These deficits in dopamine release are concomitant with disruptions in the ability to process non-drug
stimuli and the severity of these deficits correlates with negative treatment outcomes in patients. Understanding
how drug use leads to impaired stimulus processing is critical for both understanding and ultimately treating
individuals suffering from CUD.
To understand how cocaine dysregulates non-drug stimulus processing, we first need to understand
how stimuli evoke dopamine release in healthy animals (Aim 1). Dopamine is often discussed as a reward
or valence signal; however, recent work has clearly demonstrated that in the NAc both appetitive and aversive
stimuli increase dopamine release. These dopamine increases causally control learning in response to non-drug
stimuli. Thus, it is likely that dopamine in the NAc core transmits a saliency signal that notes what is important to
an animal, regardless of whether the stimulus is rewarding or aversive. In the saliency framework, both appetitive
and aversive stimuli would evoke dopamine release from the same axon terminals. However, while both aversive
and appetitive stimuli induce dopamine release in the same brain region as measured with techniques like
voltammetry, microdialysis, and fiber photometry with optical dopamine sensors, these techniques suffer from
poor spatial resolution. It is thus possible that different stimuli cause dopamine release from different pools that
are in the same region, but spatially distinct. In this framework, appetitive and aversive stimuli would evoke
dopamine release in spatially distinct patterns. Aim 1 will utilize in vivo microendoscopic imaging of dopamine
sensors to visualize spatial dopamine release in awake and behaving animals to test the hypothesis that patterns
of dopamine release are spatially distinct in response to appetitive (sucrose) and aversive (quinine) stimuli.
Are cocaine-induced deficits in dopamine release in the NAc core stimulus specific (Aim 2)? Regardless
of whether dopamine elicits distinct spatial patterns depending on the stimulus, it is well established that cocaine
exposure causes deficits in dopamine release in the NAc. It is unclear if these deficits are specific to distinct
stimuli (for example, only for rewards or only for non-drug stimuli) or occur in response to all stimuli. Using in
vivo dopamine sensor imaging with spatial resolution, Aim 2 will test the hypothesis that cocaine self-
administration reduces dopamine release in response to appetitive and aversive stimuli to a greater extent than
cocaine associated stimuli. This proposal will complement my current in vivo dopamine neuron electrophysiology
expertise while providing exceptional training in in vivo imaging of dopamine biosensors and the computational
toolkit necessary to analyze complex signaling patterns.

Public health relevance
PROJECT NARRATIVE Cocaine use disorder (CUD) is defined by a variety of symptoms, including disruptions in non-drug stimulus processing. The ability to perceive and respond appropriately to environmental stimuli is necessary for many types of learning and is dependent on dopamine release in the nucleus accumbens core. The goal of this project is to define how cocaine-induced alterations in the dopamine system disrupt spatial patterns of dopamine release in response to salient stimuli, providing a framework for how chronic cocaine use can dysregulate drug and non- drug stimulus processing.